21-006000 - NATIONAL EYE INSTITUTE (NEI) COMMUNICATIONS AND OUTREACH SUPPORT SERVICES MOD TO OPTION YEAR 1 CONTRACT 75N98020A00052 POP 9/1/2021 - 8/3

This Blanket Purchase Agreement (BPA) supports the National Eye Institute’s mission by providing resources to the NEI Office of Science Communications, Public Liaison, and Education (OSCPLE) that will broaden its areas of expertise and expand its reach in communicating with diverse audiences. The Contractor shall assist NEI in developing and implementing a communications strategy for the upcoming year by drawing on the Director’s priorities, and NEI-supported research advancements. In addition, the Contract will support eye health communications and help guide OSCPLE in using the latest digital media and evaluation tools to reach new audiences and measure the impact of its efforts. In addition, the Contractor shall assist in managing existing partnerships and identifying potential new partners for sharing resources and amplifying messages. The contractor will manage design enhancements and regular content updates to the NEI website and find creative ways to develop and repackage digital content to resonate with multiple audiences within and beyond the research community.